Motor neural dynamics of free behavior enabled through 3D computer vision

Motor systems neuroscience seeks to understand the neural mechanisms behind voluntary movement. The last two
decades have witnessed a transformation in this ﬁeld with the use of multielectrode recordings and statistical estimation
and modeling techniques. These technological advances have yielded rich, low-dimensional neural dynamics that are
suggestive of the mechanisms underlying behavior. To minimize confounds, the overwhelming majority of these studies
utilize behavioral constraint to isolate just the behaviors of interest for study. While effective for generating many behav-
iorally similar trials, this may have the unintentional consequence of artiﬁcially constraining neural dynamics to a subset
of its full range.
This project seeks to better understand whether and how neural dynamics change with respect to the behavioral context
(constrained vs unconstrained) they occur in. This type of work has historically been challenging because capturing
limb kinematics in an unconstrained setting is non-trivial. However, with recent advances in computer vision technology,
accurate 3D cameras have become accessible tools for research. This study will leverage these new 3D cameras to capture
unconstrained behavior in a large observational enclosure. Novel algorithms for the processing of these 3D datasets will
be used to estimate the subject's pose. These limb kinematics will be synchronized and correlated against neural data
recorded from one or more 96-channel Utah electrode array(s) implanted in motor regions of cortex.
Low-dimensional neural dynamics can be generated from this synchronized data. The dynamics will be explored in the
context of two behaviors in the enclosure: walking and reaching for food on the ﬂoor. The dimensionality of the dynamics
in these two contexts will be compared, with the null hypothesis stating that there is no difference in dimensionality of
dynamics between these behavioral contexts. A subsequent experiment will be to again construct low-dimensional neural
dynamics, but this time include a context of behaviorally constrained reaching. The dynamics from these three contexts
will be compared to ﬁnd a common subspace (subset of dimensions) shared among all. This subspace, if it exists (the
null hypothesis is that there is no difference in the dynamics between the behavioral contexts), represents fundamental
dynamics that are invariant of the behavioral context, suggestive of causal necessity of this subspace.
Taken together, these studies will further our understanding of how low-dimensional neural dynamics drive motor be-
havior. This insight has implications for the development of ambulatory brain-machine interfaces and may inform the
treatment of individuals with motor disorders such as stroke.

Public health relevance
Among all organs in the body, we understand the brain least–we still do not know how the brain controls movement. This work seeks to uncover explanations on how the brain controls voluntary movement in settings like walking and running. This new insight will be critical to developing better recovery treatments for people with movement disabilities.